Dissemination Core

ABSTRACT
The traditional staged pipeline for moving innovations from prototype to efficacy and effectiveness testing to real‐world
implementation generally results in slow dissemination and uptake of effective interventions and technologies. The CITEC
Dissemination Core (DC) will work to accelerate efficient and effective translation and adoption of POC technologies for
cancer screening and early detection by engaging in activities that are crucial to achieve optimal adoption and
implementation. The DC will work to: 1) ensure that clinical and user needs inform device development and design; 2)
proactively assess and address barriers to integrating POC technologies into real‐world health care delivery processes; and
3) train technology developers and end users to develop, evaluate, implement, and commercialize POC technologies for
equitable cancer screening and diagnosis. The first aim of the DC is to collaborate with the Technical and Clinical Cores to
assess, refine, formally document, and broadly communicate high‐priority unmet clinical needs associated with cancer
screening and early detection that are targets for POC technologies to improve equitable cancer screening and early
detection. The DC will carry out on‐site needs assessment visits at multiple global sites including medically underserved
settings in the US, Brazil and Mozambique. The DC will document and publish consensus POC Technology Needs
Statements each year and these will be disseminated broadly in partnership with professional societies. The second aim
of the DC is to develop an implementation science roadmap for introducing POC technologies in low‐resource settings
based on a case study around implementation of an existing but under‐utilized technology for cervical cancer screening.
The third aim of the DC is to provide a portfolio of interdisciplinary training and educational opportunities targeted to
technology developers and end‐users to accelerate the development, evaluation, implementation, and commercialization
of POC technologies for equitable cancer screening and early detection. We will partner with professional societies to
offer engaging, hands‐on pre‐conference workshops. Knowledge generated through these activities will inform and refine
the work of other CITEC cores and POCTRN centers and will help ensure that technology prototypes supported by CITEC
will have a high rate of success for market adoption, scale‐up, and implementation to address global cancer health
disparities.

Public health relevance
According to Instructions for the Submission of Mulit-Component Applications in PAR-22-203, for Administrative, Technology, Clinical and Dissemination Cores: “Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.”